Receptor Specifcity in the Proliferation and Differentiation of Stem Cells

DESCRIPTION (provided by applicant): The goal of this application is to test a candidate "universal" cell growth switch, a conditional derivative of the fibroblast growth factor receptor 1, F36VFGFR1, in preclinical models of gene and cell therapy. In specific aim 1, we will test whether different growth factor receptor signaling domains differentially regulate human hemopoiesis. In specific aim 2 we will compare the nature, intensity and duration of the hematopoietic response to F36VFGFR1 signaling versus F36Vmp1 signaling in dogs. In specific aim 3 we will test whether F36VFGFR1 signaling promotes self-renewal in engineered human embryonic stem (ES) cells. We will be using the human embryonic stem cell line WA01.